Therapeutics for Rare and Neglected Diseases - Science

Since TRND was announced only on May 20, 2009, all of the science done this FY was "start-up" in nature, pertaining to needs assessment and establishing processes for selection of scientific projects to be adopted by TRND and the starting and stopping points for such projects. Specific accomplishments include: 1. Determined governance of TRND and received nominees from numerous ICs for a Trans-NIH Staff Advisory Group (TAG) and an External Expert Panel (EEP). 2. Hired a Senior Scientific Communications Coordinator to act as executive secretary for the TAG and EEP and to coordinate communications. 3. Participated in numerous meetings with companies, academic scientists, and individuals from disease communities interested in learning about TRND. 4. Explored potential partnerships with interested stakeholders in RNDs to seek opportunities to leverage TRND activities.